The TMS-evoked potential as a measure of cortical excitation and inhibition during cognitive processes

ABSTRACT
Non-invasive recordings of human brain activity – be it of BOLD or neural field potentials – all share a common,
insurmountable weakness: it is impossible to identify whether amplitude changes to these signals are due to the
excitation or inhibition of their neural generators (i.e., the underlying patches of cortex). Hence, there is a critical
need to develop non-invasive measures of the moment-to-moment physiological excitability of the human cortex.
Such a method exists for primary motor cortex. The TMS-induced motor evoked potential (MEP) in the
electromyogram indexes the physiological excitability of cortico-motor tracts originating in primary motor cortex
(M1). The MEP increases alongside motor-neuron firing during movement preparation and decreases alongside
reductions in M1 firing during movement cancellation. Here, we aim to test whether a signal with similar
properties can be derived outside of M1. Specifically, we aim to test whether the TMS-evoked potential (TEP)
in EEG recordings from human cortex similarly reflects changes in the cortical excitability of that underlying
cortex evoked by cognitive processes. The TEP is an EEG amplitude deflection that occurs after single pulses
of TMS applied anywhere on the brain.
We will use a cognitive task to differentially induce the excitation and inhibition of the same cortical region
outside of M1: the frontal eye fields (FEF). The firing rate of FEF neurons is known to increase during memory-
guided saccades and decrease during the anticipation of anti-saccades (while notably, non-invasive BOLD
recordings show signaling increases in both conditions). We will perform an MRI-guided, sham-controlled
investigation of combined EEG and TMS to test whether the TEP – unlike fMRI or EEG – faithfully indexes these
changes in task-related neuronal firing. If so, this work would provide fundamentally novel, original method to
non-invasively measure the excitability and inhibition of cortical areas outside of M1.

Public health relevance
NARRATIVE Non-invasive recordings of human brain activity cannot identify whether the parts of the brain that generate them are undergoing excitation (increased neuronal firing) or inhibition (decreased neuronal firing). We aim to develop a novel non-invasive measure of this moment-to-moment physiological excitability of the human cortex by using the TMS-evoked potential (TEP) – an amplitude deflection in EEG recordings of human cortex that can be elicited by TMS stimulation. We will systematically elicit excitation or inhibition of the same brain area using cognitive processes known to differentially increase or decrease that area’s neuronal firing. We will then test whether these changes are reflected in amplitude changes of the TEP.